Core-002

Abstract
Structure-based vaccine design holds great promise for combatting viral pathogens that create substantial
burdens on global health. For HIV, the soluble ectodomain of the envelope glycoprotein (Env), which is the
primary target for neutralizing antibody responses, is the focal point for vaccine design. Several different
platforms of stable, soluble Env trimers locked in a prefusion, antigenically optimal, conformation are now
available and provide the basis for further design efforts. The investigators of this grant developed the native
flexibly-linked (NFL) platform, which does not require furin cleavage. The Ward and Wilson labs (Co-PIs of the
Structure Core) have shown that NFL trimers adopt native-like structures and the Wyatt lab (Project 1) that they
induce neutralizing antibody responses in rabbits and guinea pigs. In fact, a small subset of monoclonal
antibodies that have been isolated from these animals show some neutralization breadth, a key next step in
trimer-based vaccine design. We have already mapped these antibodies by electron microscopy and showed
that one antibody targets an epitope that overlaps with the CD4bs and another targets an epitope near the base
of the trimer, similar to some known human broadly neutralizing antibodies. These desirable immune responses
are relatively infrequent, but show the promise of these trimer-based immunogens. Based on new structural
information and the desire to improve the antigenicity and immunogenicity, further NFL trimers are continually
being redesigned. For example, the NFL platform has been elaborated to include the MPER as well as a glycan-depleted version that increases accessibility of the CD4bs, and has been successfully been incorporated into
liposomes for multivalent presentation. Each new design was enabled by the available structural information.
Hence, this core will continue to provide the necessary structural information to drive Env trimer vaccine
innovation in an iterative manner, at the front-end aiding in the design of new immunogens (with Project 1), in
the middle by informing boosting strategies using our EM serum profiling analysis (with Project 2), and at the
back-end by evaluating the antibody responses to such immunogens at low and high resolution (with Project 2).